Unobtrusive Monitoring of Affective Symptoms and Cognition using Keyboard Dynamics

The goal of the parent project “Unobtrusive Monitoring of Affective Symptoms and Cognition using Keyboard Dynamics (UnMASCK)” is to develop digital biomarkers derived from smartphone typing dynamics and motor kinematics which can be used to predict alterations in brain network properties associated with cognitive dysfunction and prospective changes in clinical mood symptoms. The digital data is unobtrusively collected via a novel platform “BiAffect” in a transdiagnostic sample of subjects with mood disorders and health controls. The BiAffect platform collects metadata related to typing behaviors such as keypress types, timestamps, and accelerometry and uploads these data to the study server. Subject specific summary metrics are calculated locally and presented to the user via a dashboard. With this supplement our goal is to update the software infrastructure of the BiAffect platform in order to facilitate interoperability, collaboration with other researchers, and integration with the smartphone hardware and operating system upgrades. To achieve these goals, we plan to refactor the BiAffect codebase to enable more robust multi-developer collaboration and version control. We also plan to create standardized data processing pipelines to support collaborations with researchers who may have varying levels of capacity for data science and engineering.

Public health relevance
PROJECT NARRATIVE Mood disorders are associated with significant financial and health costs for the United States, partially due to cognitive problems in these patients that can worsen disease course and impair treatment response. This study proposes to use smartphone-based technology to monitor cognitive problems in patients with mood disorders by linking brain network changes with predicted worsening of mood symptoms. The proposed study will provide evidence for using smartphone-based passive sensing as a cost-effective way to predict illness course and treatment response.